Glut1 and the microvascular complications of diabetes

The goal of this proposal is to determine whether systemic reduction of the facilitative glucose transporter,
Glut1 (Slc2a1), prevents the major microvascular complications of diabetes: diabetic retinopathy (DR), diabetic
kidney disease (DKD) and diabetic peripheral neuropathy (DPN) and/or augments the current standard of care
for Type 2 diabetes. Each microvascular complication is mitigated by tight glycemic control, but efforts to maintain
euglycemia in diabetic patients has been elusive. Here, we will investigate whether the systemic reduction of
Glut1 using a genetic approach prevents DR, DKD and DPN phenotypes in mouse models of both Type 1 and
Type 2 diabetes for the following reasons: (1) Glut1 is highly expressed in the retina and the cells that comprise
the inner and outer blood retinal barriers, throughout the nephron and tubules of the kidney and in the paranodal
region of the peripheral nerves as well as the Schwann cells that surround the nerves. (2) Reduction of Glut1 in
the eye via pharmacology, siRNA or genetic approaches reduces hallmarks of DR and reduction of Glut1 in
mesangial cells of the nephron prevents DKD phenotypes in mouse models of Type 1 diabetes. (3) Inhibition of
the sodium-glucose cotransporter-2 (Sglt2) is insufficient to fully prevent DR, DKD and DPN phenotypes. (4)
Small nucleotide polymorphisms in Glut1 are associated with increased risk of both DR and DKD. (5) Intensive
insulin therapy, which lowers prevalence of DR, DKD and DPN can regulate Glut1 at both transcription and post-
translational levels. Because Glut1 is elevated in the diabetic retina and kidney, reduced Slc2a1/Glut1 expression
and increased Glut1 turnover may contribute to the mechanism by which intensive insulin therapy reduces DR,
DKD and DPN.
These observations form the premise for our hypothesis that reduction of Glut1 will prevent the
microvascular complications of diabetes, augment the current standard of care for Type 2 diabetes, and
contributes to the mechanism by which intensive insulin therapy confers protection against DR, DKD
and DPN. We will test this hypothesis with the following specific aims. In Aim 1 we will utilize the Glut1+/- mouse
which harbors a hemizygous Glut1 deletion to determine if systemic reduction of Glut1 prevents DR, DKD and
DPN in a STZ-induced mouse model of Type 1 diabetes or in the Leprdb/dbeNOS-/- mouse model of progressive
Type 2 diabetes. We will further determine if the addition of systemic Glut1 reduction to the current standard of
care for Type 2 diabetes, treatment of hyperglycemia (metformin), hypertension (ramipril) and inhibition of Sglt2
(empaglifozin), augments protection from diabetic phenotypes. In Aim 2 we will test the hypothesis that intensive
insulin therapy regulates Glut1 by utilizing the STZ-induced mouse model of Type 1 diabetes. Activation of the
Forkhead Box O transcription factor, FOXO1, downstream signal transduction molecules, and Slc2a1 mRNA
levels will be measured in each microvascular tissue to determine if Glut1 can be regulated by insulin
transcriptionally. Activation of the ubiquitin-proteasome pathway and Glut1 protein levels will additionally be
measured to interrogate post-translational control of Glut1 by insulin.
These experiments will reveal whether Glut1 contributes to the development of DR, DKD and DPN in
Type 1 and/or Type 2 diabetes and if targeted reduction of Glut1 can be considered for the future development
of novel therapeutics for the treatment of these pathologies. Nearly 25% of veterans are affected by diabetes,
making the care and treatment of DR, DKD and DPN of great significance for the VHA.

Public health relevance
The major microvascular complications of diabetes include diabetic retinopathy, diabetic kidney disease and diabetic peripheral neuropathy, each of which can significantly reduce quality of life and increase mortality by causing blindness, end-stage renal disease and lower-limb amputation, respectively. Because nearly 25% of veterans are affected by diabetes, it is important to identify ways to prevent these complications. The goals of this proposal are to (1) determine whether systemic reduction of the facilitative glucose transporter, Glut1, prevents these complications, (2) to determine whether the addition of Glut1 reduction to the current standard of care for Type 2 diabetes augments protection against each complication and (3) to elucidate mechanisms that regulate Glut1 in each tissue.